FAMILIAL DETERMINANTS OF HYPERTENSION

The purpose of this study is to identify African American sib pairs with hypertension. These individuals will be potential subjects for subsequent studies related to heratibility of blood pressure and physiologic characteristics associated with hypertension.